FASEB's The Autoimmunity Conference

PROJECT SUMMARY There has been enormous growth in the past few years in our understanding of pathogenic mechanisms in autoimmunity, and a new recognition of the similarities and important distinctions between different autoimmune diseases. Examples of rapidly moving areas of research in autoimmunity are the identification and characterization of subsets of pathogenic T and B cells that secrete unique inflammatory mediators and novel insights into the interface between genetic susceptibility, environmental stress, and the microbiome and metabolome. These findings have emerged largely from the work of basic scientists and the FASEB summer conference on Autoimmunity has historically focused on discussion of new findings in basic research. However, we believe that it is crucial for basic scientists to establish and maintain connections to scientists who are working to translate mechanisms into therapeutic targets. For example, the unexpected efficacy of therapeutic B cell depletion in some autoimmune diseases has prompted intense investigation by basic scientists into the role of B cells in pathogenic pathways. Likewise, the understanding of the role of the microbiome influencing immune regulation has led to the discussion and development of potentially novel therapeutic strategies for other illnesses, such as inflammatory bowel disease and rheumatoid arthritis. Basic information on metabolism in regulatory and effector T cells has spurred interest in the drive toward metabolic manipulations as therapeutic strategies, not only in cancer, but also in autoimmunity. Notably one of the major complications of cancer immunotherapy with checkpoint inhibitors is the development of a wide-range of autoimmune complications. Therefore, while maintaining a focus on cutting edge basic research in autoimmunity, we will continue to involve translational scientists that study mechanisms of tissue injury in human disease to discuss novel treatment strategies and data on the successes and failures of manipulating the immune system in autoimmune humans and cancer patients. We expect that emphasis on therapeutic treatment of autoimmune disease will attract both basic and industry scientists and will stimulate strong interest among both junior and established investigators. Our program combines a focus on diversity with an emphasis on involving and mentoring trainees at all levels. The size and setting of this meeting are ideal to promote the open exchange of data and cross-fertilization of ideas that will stimulate new hypotheses and attract more trainees into autoimmunity research.

Public health relevance
PROJECT NARRATIVE Autoimmune diseases are chronic, debilitating illnesses, and result in significant decrease in quality of life. The incidence of autoimmunity has risen over the past decade such that collectively these diseases exert a significant economic toll on society due to co-morbidities, loss of livelihood, and cost of health care. The goal of the FASEB Science Research Conferences on Autoimmunity is to provide a forum for the exchange of data, ideas, and hypotheses generated by collaborating basic and applied scientists to catalyze the development of new treatments for autoimmune diseases.